Mentoring and Patient-Oriented Research in Clinical Informatics and Data Science

This K24 mid-career investigator award in patient-oriented research is to support the mentoring, research, and
career development activities of Dr. Tell Bennett. Dr. Bennett is an Associate Professor in the University of
Colorado School of Medicine and a practicing pediatric ICU physician and informaticist/data scientist with
research concentrations in predictive analytics, electronic health record (EHR) data, and clinical decision
support (CDS) tool implementation. He is the Informatics Director for the Colorado Clinical and Translational
Sciences Institute (CCTSI) and Vice Chair of Clinical Informatics in the Department of Biomedical Informatics.
His combined leadership roles have enabled him to build a rich mentoring environment for patient-oriented
informatics research. This K24 application proposes to sustain and grow that mentorship program. He currently
mentors clinician-scientists in a variety of clinical fields including intensive care, pharmacy, surgery,
endocrinology, malignant hematology, and clinical psychology. The K24 Mentoring Plan aligns with Dr.
Bennett’s mission to grow patient-oriented research using informatics and data science methods and tools.
The mentoring plan leverages educational, career development, and research support programs available
through the CCTSI and the new Department. The K24 Research Plan is to develop and implement machine
learning and computational physiology models deployable as EHR-based CDS tools. Dr. Bennett currently
leads and mentors projects developing CDS tools in both outpatient and inpatient care settings and in a variety
of clinical domains include heart failure, traumatic brain injury, serious bacterial infection and sepsis, COVID-
19, thyroid cancer, and postpartum depression. In this K24, developing CDS tools to improve decision-making
and outcomes in children with acute respiratory failure (ARF) is a natural next step in this work. ARF is a
common, important, and NIH-relevant condition that causes significant pediatric morbidity and mortality. The
aims of the project are to 1) develop and validate a dynamic machine learning-based real-time prediction
model for intubation in children with ARF and 2) phenotype current lung injury state in mechanically ventilated
children using computational physiology models. These models can be deployed as CDS tools and tested as
interventions in future clinical trials to improve patient outcomes. The K24 Career Development Plan includes
formal mentorship training and coursework in signal processing and dynamical systems models. This group of
skills will make Dr. Bennett a more successful mentor.

Public health relevance
Acute respiratory failure is common in children and can cause death if clinicians do not support a child’s breathing correctly. This project will develop tools based on machine learning and mathematical models to help clinicians decide how best to support a child’s breathing. This K24 award will support the applicant to increase his available time and effort to mentor junior investigators and to conduct patient-oriented research using informatics and data science methods.